Gamma-2 Herpesviruses as Vaccine Vectors for AIDS

Results of both monkey and human trials have highlighted the difficulties in achieving vaccine protection
against SIV and HIV. Persistent, recombinant herpesviruses are being used in monkeys to try to match the
degree of protection that can be achieved with live attenuated strains of SIV. Results to date have been
promising but the absence of anti-Env antibody responses from the recombinant herpesviruses has been a
glaring deficiency. The proposed experiments will overcome this deficiency and allow full testing of the
promise of this approach.

Public health relevance
The proposed experiments will allow a greater appreciation of the potential for recombinant herpesviruses in particular, and persistent vectors in general, for their capacity to provide protection against AIDS virus exposure. If shown to be significantly better than other vaccine approaches, it will shape the emphasis for ongoing preclinical vaccine discovery research.